COBRE Phase III

Overall – Project Summary/Abstract
The overall goal of the Center for Studies of Host Response to Cancer Therapy at the University of Arkansas for
Medical Sciences (UAMS) is to become a self-sustaining multidisciplinary center for research excellence that
contributes to our understanding of mechanisms for side effects of cancer therapy, identifies methods for early
detection, and develops strategies to prevent or treat such side effects. The Center accomplishes this overall
goal by assisting junior investigators with research programs in this common theme establish themselves as
independent scientists, providing opportunities for established investigators to collaborate and expand their
capacities in this area, and strengthening the research infrastructure for all at UAMS. Achieving these goals will
create a vibrant, multidisciplinary, yet synergistic research environment. To our knowledge, few research centers
focus on cancer survivorship, and none take the paradigm-shifting approach of proactively addressing treatment-
related toxicities to improve overall cancer treatment outcomes. During Phases 1 and 2, the Center has grown
significantly in critical mass and is spanning the full translational spectrum from basic to clinical research that is
funded by a number of federal and private sources. Several research core facilities provide services that enhance
the research of Center members. In Phase 3, the Center will strengthen its research portfolio by bringing in new
investigators and supporting team collaborations (Specific Aim 1); advance the Center’s technical cores to being
self-sustaining by ensuring that they are run by expert personnel, adjusting core services in response to
institutional needs assessments, and continuing to advertise the services to grow the user base (Specific Aim
2); and ensure that the Center becomes self-sustaining (Specific Aim 3). The Center will consist of an
Administrative Core (Core A) that will continue to oversee the Center’s pilot project program, and 2 technical
cores: the Bioanalytical Core (Core B) and Radiation and Imaging Core (Core C). Strengthening our interactions
with the 6 other COBRE Centers and additional NIH-supported programs that enhance biomedical research in
Arkansas will also contribute to establishing the Center as a self-sustaining research program that is well-
integrated in the institution. The Center’s progress will be guided by a comprehensive evaluation plan and a
highly qualified Advisory Committee. Strong institutional support combined with active interest from funding
agencies in improving uncomplicated cancer cure rates and the quality of life of cancer survivors ensures a high
likelihood of lasting success for the Center for Studies of Host Response to Cancer Therapy.

Public health relevance
Overall – Narrative Many patients and survivors of cancer suffer from adverse effects of treatment that can present during and after the completion of cancer therapy. The COBRE Center for Studies of Host Response to Cancer Therapy brings together and supports investigators from various disciplines who perform research to understand mechanisms by which cancer therapy causes adverse effects, identify new methods for early detection of side effects, and develop novel strategies to reduce them. The overall goal is to build a self-sustaining center for research excellence that aids in making cancer treatment safer.